The University of North Carolina-Kinshasa School of Public Health Research Partnership in the Democratic Republic of Congo; a Model for Improving Women'sand Children's Health Through Research

Abstract
The Democratic Republic of Congo (DRC) is among the poorest nations in the world with correspondingly poor
health outcomes. Innovative research is urgently needed to discover evidence-based interventions to improve
health outcomes in low and middle-income countries. The health care environment and outcomes in the DRC
are emblematic of problems encountered in many low and middle-income countries making the DRC an ideal
environment in which to develop and test strategies for improving the health of women and children in these
countries. The University of North Carolina at Chapel Hill (UNC) and the Kinshasa School of Public Health
(KSPH) in the DRC have had a longstanding partnership whose overall goal is to expand scientific knowledge
relevant to improving health outcomes. The Partnership, led by Drs. Antoinette Tshefu (KSPH; SFI) and Carl
Bose (UNC; PI), has been highly productive in a wide range of hospital and community-based research
studies, and has the expertise and resources to address research questions in a variety of areas of maternal
and child health. Therefore, the UNC-KSPH Partnership is an ideal candidate to continue membership in the
NICHD Global Network for Women’s and Children’s Health Research (GN). Our overall goal is to discover
evidenced-based strategies to improve health outcomes in low and middle-income countries. To achieve this
goal we will: 1) bring to the GN the unique, multi-disciplinary resources in population sciences and translational
research of the UNC-KSPH Partnership; 2) strengthen the investigative capacity in the DRC by improving the
research infrastructure; and 3) develop young physician-scientists in the DRC and the US by providing
opportunities for post-graduate study and leadership of GN activities.

Public health relevance
Project narrative By submitting this application, the UNC-KSPH Partnership will re-compete for the NICHD Global Network for Women’s and Children’s Health Research (GN). Our overall goal is to discover evidenced-based strategies to improve health outcomes in low and middle-income countries. To achieve this goal we will: 1) bring to the GN the unique, multi-disciplinary resources in population sciences and translational research of the UNC-KSPH Partnership; 2) strengthen the investigative capacity in the DRC by improving the research infrastructure; and 3) develop young physician-scientists in the DRC and the US by providing opportunities for post-graduate study and leadership of GN activities.